Interplay between LINE-1 retrotransposons, condensins, and IFN

Project summary- Longworth, Michelle S.
The expression and retrotransposition of Long Interspersed Element-1s (L1s), a type of
endogenous retroelement (RTE), induces Type I IFN (IFNα and IFNβ) in epithelial cells through
activation of Pattern Recognition Receptors (PRRs) including retinoic acid-inducible gene I
(RIG-I)-like receptors (RLRs). Interferon stimulated genes drive mechanisms which repress L1,
as part of a feedback loop, and which can also lead to cell death. Therefore, RTE/L1 de-
repression and subsequent IFN induction (termed viral mimcry) is currently being studied as a
potential mechanism to kill cancer cells, and a better understanding of the underlying
mechanisms will benefit cancer therapeutic development. Our lab discovered that condensin I
and condensin II complexes inhibit endogenous and transfected L1 expression and
retrotransposition in primary and transformed epithelial cells. Condensins are essential, multi-
subunit complexes that are known for their canonical functions in organizing the genome. Our
preliminary data show that condensin I and condensin II proteins are necessary for L1-mediated
induction of Type I IFNs in both cancer-derived and primary epithelial cells, and may cooperate
with one another in the cytoplasm to induce IFN. Importantly, condensin insufficient cells fail to
induce transcription of Type I IFN, even though endogenous L1 expression is increased, placing
condensin proteins downstream of L1 in this pathway and suggesting a novel role for
condensins in RTE-mediated innate immune signaling. The overall objectives of this proposal
are to determine how L1 expression influences condensins to promote Type I IFN transcription
and uncover novel roles for condensins in L1-mediated innate immune signaling responses. Our
central hypothesis is that condensin I and condensin II complexes cooperate to promote RLR
pathway-driven Type I IFN induction in response to increased levels of L1 RNA. We will test this
hypothesis through the following aims: AIM 1. Determine whether increased L1 RNA levels
impact condensin protein localization, association, and activity, and AIM 2. Identify the
mechanisms by which condensin proteins facilitate Type I IFN induction in response to L1
expression. The expected outcomes of the proposed work include the identification of new roles
for condensins in innate immune signaling, identification of potential roles for cytoplasmic
condensin proteins, and a better understanding of how L1 expression facilitates Type I IFN
induction in both tumor-derived and primary cells. These findings will lay the foundation for
future development of novel therapeutics that modulate RTE-mediated IFN induction to kill
cancer cells.

Public health relevance
Project Narrative- Longworth, Michelle S. The de-repression of retrotransposable elements (RTEs) within the human genome leads to upregulation of Type I IFNs which can cause cell death, and this is currently being explored as a potential mechanism to kill cancer cells, in combination with immune checkpoint inhibitors. We discovered that condensin complexes are necessary for the ability of RTEs to induce IFN in epithelial cells (the most common cell type that develops into solid tumors), and in this proposal, we will determine how RTE expression influences condensins to promote Type I IFN induction and uncover novel roles for condensins in RTE-mediated innate immune signaling responses. Results will expand our knowledge of how RTEs activate innate immune responses, and identify new pathways that can be modulated to enhance cancer therapies that rely on RTE-mediated IFN induction to kill cancer cells.